Device for Preservation of Cell Free RNA in Saliva

ABSTRACT
Early detection is critical to cancer mortality reductions, and yet the breast imaging clinic visits required for
these life-saving early detection programs are inaccessible to disadvantaged, remote, or quarantined
populations with limited medical facility access. In fact, breast cancer surveillance programs this year have
stalled by as much as 90% versus their pre-pandemic rates, resulting in risky delays in new cancer diagnosis
[1]. A saliva-based test for early detection could transform today’s screening paradigms. A promising biofluid
for disease detection, saliva can be self-sampled non-invasively, without trained technicians. Saliva is ideal for
at-home and other non-clinical site collection; it contains a variety of analytes including exosomes, RNA, DNA,
proteins, metabolites, viruses and oral microflora, and is a powerful window on health and disease. Recently,
saliva samples have shown better clinical utility vs. nasal swabs for detecting COVID-19 [2]. Mounting
evidence exists for oral microbiome links to systemic disease [3], and salivary biomarkers diagnose complex
traits such as pediatric medical conditions, traumatic brain injury, autism, and cancer [4-7]. A commercial
saliva-based test for autism is based on 32 human and microbial RNA markers [8]. In many complex trait
studies, saliva is frozen as cell-free supernatant. The most prevalent saliva collection and preservation
devices, although easy-to-use, preclude effective cell-free RNA and exosome analysis, since saliva samples
are treated with lysis reagents resulting in mixed populations of cellular and non-cellular RNAs, increasing
noise and damaging performance characteristics. Saliva collection devices that instead use membranes to
separate cells suffer from inefficient recovery of critical analytes, either because they lack appropriate
preservatives or because they adsorb and therefore lose, a substantial analyte fraction. To enable widespread
use for disease detection, new standardized methods are needed to preserve cell-free saliva and retain the
integrity of its key constituents for stable transport and downstream analysis. This project extends our past
SBIR grant work and our own internal research, to develop an easy-to-use saliva collection and preservation
device to stabilize cfRNA and other analytes, enabling us and others to efficiently collect high-quality clinical
saliva samples. Using RT-qPCR assays and RNA isotype profiles, we will characterize salivary cfRNA integrity
and stability over timelines sufficient for remote collection and transport. Armed with well-characterized RNA
decay profiles, we propose an iterative design-of-experiment approach to prototype a versatile device to collect
and preserve saliva at room temperature (RT), stabilizing RNA while also preventing cell lysis and bacterial
growth. Our device performance validation will use prospectively collected and preserved saliva from >50
women to demonstrate stability for up 72 hours at ambient conditions. This device will standardize methods for
collection, stability, and transport of saliva, key to driving virtualized sample collection and healthcare in
cancer, viral, and other diagnostics, increasingly critical to a post-pandemic world.

Public health relevance
Project Narrative Our work focuses on the development of a saliva preservation device that is compatible with at home self-collection of samples for screening and diagnostic testing. The unique properties of the device will enable the broader use of saliva for a wide variety of tests at population scale and facilitate the paradigm shift from doctor’s office visits to virtualized medicine for healthcare in a post-COVID-19 pandemic world.